Decoding Viral Control of Host Kinase Signaling to Design Combination Therapy

PROJECT SUMMARY
Severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) is a single-stranded RNA beta-coronavirus of
the family Coronaviridae that emerged in late 2019 and causes the infectious disease COVID-19 (Coronavirus
Disease-2019). The emergence of the global pandemic has resulted in a public health emergency with
detrimental societal and global economic effects. At present, there are no vaccines or curative treatments
available. The search for antiviral therapies constitutes a global research priority. Combinatorial host-directed
antiviral treatments present a low propensity for resistance and a high potential for potent efficacy.
Pathogens often provoke dramatic changes to host cellular signaling to enhance their fitness. Proteomic
approaches that globally quantify changes in protein abundance and phosphorylation represent an unbiased
way to elucidate how host pathways are rewired during infection. We previously observed that SARS-CoV-2
provokes dramatic changes to host phosphorylation, suggesting the regulation of host kinases to be an important
mediator of coronavirus infection and disease. We additionally found many SARS-CoV-2 proteins to physically
interact with several human kinases. Furthermore, we and others have shown that targeting host kinases
hijacked by SARS-CoV-2 is an effective means of discovering antiviral therapies. We identified 49 kinases to be
dysregulated during infection—including p38, casein kinase II, cyclin dependent kinases, AXL, and PIKFYVE—
finding 38/68 (>50%) drugs targeting these kinases to be antiviral in cell culture assays (CC50/IC50>10).
Here, I propose to expand upon my prior work by (Aim 1) mapping the global regulation of host phosphorylation
signaling by SARS-CoV-2 and OC43, a non-lethal coronavirus and cause of common cold, infection in human
cells using mass spectrometry-based proteomics to identify novel kinases and pathways dysregulated during
coronavirus infection. Next, I will (Aim 2) validate coronavirus dependency on host responses and use this
information to design and test novel combination therapy to treat infection in human cell culture models. Lastly,
I will (Aim 3) decode how kinases impinge upon the coronavirus life cycle as well as how kinases control
phosphorylation of viral/host proteins during infection. This systematic approach will shed light on coronavirus
biology and therapeutic strategies, with general applicability to other infectious agents and diseases.
My request for additional mentored training is based on a need to master skills in (1) mass spectrometry-based
proteomics, (2) virology theory and methods, and (3) functional genetics. My background is in mathematical
modeling, bioinformatics, and cancer, which I plan to integrate with skills in proteomics, genetics, and virology to
gain independence from my advisor and start a dual wet/dry independent research lab studying post-translational
modifications and signaling rewiring in infectious disease and cancer. My mentor, co-mentor, and advisory
committee will train and mentor me as I progress towards becoming an independent investigator.

Public health relevance
PROJECT NARRATIVE This research promises to increase our understanding of how SARS-CoV-2 hijacks host cellular machinery for survival and how we can interrupt this process by repurposing common host-directed drugs and compounds. The relevance of the proposed research to public health lies in its ability to reveal new therapeutic strategies to treat COVID-19, and potentially other viruses, embedded within a global knowledge of how the virus exploits mammalian cellular signaling. This pertains to NIH’s mission to develop fundamental knowledge that will help understand and treat disease.